Computational approaches for elucidating proteomes and interactomes

Proteins and their interaction networks play crucial roles in virtually all cellular processes. As
such, knowledge of their functioning is essential for understanding the molecular basis of life.
While high-throughput experimental methods are routinely used to characterize proteins and
catalog their interactions, the overwhelming amount of genomic variation both within and across
organisms—and in healthy and disease states—necessitates the development and use of
efficient computational methods. Our overarching goal is to devise algorithms and machine
learning methods that yield a predictive understanding of proteins and their specificities,
interactions, and networks, and of how these attributes are altered by genetic variation. This is
an especially exciting time to develop methods for analyzing protein sequences, as in recent
years the field has been transformed by new artificial intelligence technologies, including protein
language models that, akin to the progress in natural language processing, learn the “language”
of proteins. In the next five years, we will combine these groundbreaking technologies with our
years of domain expertise on proteins and their networks to tackle fundamental problems in
three important areas. First, we will develop powerful new machine learning methods to predict
DNA-binding specificities for broad classes of transcription factor proteins; such methods will
newly enable the inference of regulatory interactions mediated by uncharacterized transcription
factors or those mutated in disease, significantly advancing upon current work that is focused
just on specific transcription factor families. Second, we will develop highly scalable, sequence-
based approaches to predict the specific functional effects of variants within proteins; these
approaches will be a great aid in interpreting the millions of coding variants observed across
human populations and will be a step towards obtaining a mechanistic understanding of disease
mutations. Third, we will develop novel algorithmic and machine learning approaches to predict
the targets of kinase proteins and the pathways they regulate; these methods will elucidate
kinase signaling networks and help decipher the growing body of complex phosphoproteomics
datasets. A final, cross-cutting goal of our research is to rigorously evaluate current protein
language models in order to uncover their strengths and limitations, and to develop innovative
strategies to improve their capacity to capture the syntax, grammar, and semantics of protein
sequences. We will release open source software for all developed methods.

Public health relevance
Narrative The proposed research will yield new computational methods and software tools for deciphering genomes at the level of proteins. We will develop methods that further our understanding of proteins and their functions, specificities, and networks, and of how they are altered by genetic variation. Since proteins play an important role in virtually all biological processes, and many human diseases are caused by variants within protein sequences, this research will expand our understanding of cellular functioning in healthy and disease contexts, and will provide new avenues for diagnosis and treatment.